Role of Focal Adhesion Kinase (FAK) in Nephrosis and Nephritis

DESCRIPTION (provided by applicant): Chronic kidney disease (CKD) often leads to irreversible deterioration of renal function and progresses to End Stage Kidney Disease (ESKD). CKD has emerged as a serious public health problem and data obtained from the USRDS reveals that the number of new cases of ESKD in the United States is projected to be 650,000by 2010, with accompanying Medicare expenditures of $28 billion. As glomerular diseases secondary to podocyte dysfunction contribute up to 90% of all ESKD, a detailed molecular and genetic approach to identify mechanisms for podocyte development and repair may give us new insights for developing therapeutic agents and targets. Currently the therapeutic options available to treat glomerular diseases are limited to Angiotensin Receptor Blockers. Angiotensin Converting Enzyme Inhibitor, Steroids, and Alkylating Agents. As many patients treated with these agents still progress to ESKD, this suggests that other mechanisms responsible for injury are likely involved. When podocytes are damaged, the cell body retracts resulting in effacement and subsequently, proteinuria. For effacement to occur, cells must regulate adhesive contacts between the glomerular basement membrane and the extracellular matrix, which is comprised of focal adhesions and integrins. The goal of this research project is to define the role of focal adhesion protein, Focal Adhesion Kinase (FAK), a critical regulator of cell movement, in podocyte regulation following injury. Preliminary results demonstrate that FAK is highly activated following podocyte injury and a conditional knockout mice lacking podocyte FAK expression appear resistant to injury in murine modes of nephrotic and nephritic syndromes. The aim of the current proposal is to assess the functional relevance of FAK activation by inducing podocyte injury in-vivo and by knocking down podocyte FAK expression with shRNA, and mutating critical FAK regulatory sites in-vitro (Specific Aim 1). As a novel specific FAK inhibitor (Novartis) is currently available, the functional response to FAK inhibition in vivo will be tested before and after podocyte injury in mice using this compound (Specific Aim 2). Finally, to address FAK's role in its regulation of downstream signaling molecules such as inducing matrix metalloproteinase 2 (MMP-2) activity, mice as well as cell culture models defined in the first two specific aims will be utilized to determine the mechanism inducing injury (Specific Aim 3).

Public health relevance
PUBLIC HEALTH RELEVANCE: Kidney injury that results in inflammation, loss of protein, and blood in the urine often leads to irreparable damage that ultimately requires a kidney transplantation and/or dialysis to treat the affected patient. In the United States, the number of new cases of chronic kidney disease is projected to be greater than 650,000 by year 2010. Currently there are a limited number of therapeutic options available. The goal of the proposal is to define the mechanisms that are involved during kidney injury and to utilize inhibitors that antagonize against the offending agent(s) responsible for disease progression. Kidney injury that results in inflammation, loss of protein, and blood in the urine often leads to irreparable damage that ultimately requires a kidney transplantation and/or dialysis to treat the affected patient. In the United States, the number of new cases of chronic kidney disease is projected to be greater than 650,000 by year 2010. Currently there are a limited number of therapeutic options available. The goal of the proposal is to define the mechanisms that are involved during kidney injury and to utilize inhibitors that antagonize against the offending agent(s) responsible for disease progression. __SpecificAimsTextDelimiter__ A. Specific Aims- Glomerular diseases account for 90% of End Stage Kidney Disease (ESKD). The glomerulus forms the kidney's filtration barrier and is composed of a fenestrated endothelium, glomerular basement membrane, and the podocytes which interdigitate to form slit diaphragms. When the podocytes are damaged, foot process fusion occurs, as does migration of podocytes into crescents that form along the parietal basement membrane. This involves the rearrangement of the actin cytoskeleton (1), and retraction of the processes towards the cell body, allowing mechanical forces and signaling events to be transmitted into the cell. These events are likely to alter focal adhesion signaling, but have not been studied to date. Focal Adhesion Kinase (FAK) localizes to the focal adhesion complex and is a key mediator of focal adhesion disassembly and actin rearrangement (2,3). FAK is required for normal development, and mice lacking FAK die at ~E8.5 (4), prior to kidney development at E11.5 (5). We have demonstrated that following podocyte injury in- vivo and in-vitro, FAK expression and activation are significantly increased in wild type mice. We therefore hypothesized that FAK activation may play a critical role in podocyte responses following injury by activating signals that induce focal adhesion turnover, resulting in foot process retraction, leading to effacement, and proteinuria. To test this hypothesis, we established a conditional knockout of FAK in podocytes using the Cre- LoxP system. These mice are born without evidence of podocyte/glomerular developmental defects. However, they are partially resistant to the foot process fusion and subsequent proteinuria that typically accompanies LPS and rabbit-anti-mouse GBM induced podocyte damage. In addition, podocytes stably expressing FAK shRNA-mir and primary cultures of FAK null podocytes also demonstrate failure of LPS induced podocyte migration. Hence, the experiments proposed in Specific Aim 1 will use in-vitro and in-vivo models of podocyte injury to specifically define the role of FAK activation in the destabilization of podocyte foot processes. Specific Aim 2 will determine if the FAK inhibitor, TAE-226, can reduce podocyte injury in rodent models of nephrotic and nephritic syndromes and lastly, Specific Aim 3 will determine the importance of metalloproteinase activity and actin rearrangement as downstream effectors of FAK-mediated foot process destabilization. Hypothesis: FAK activation in injured podocytes stimulates the disassembly of focal adhesions, thus destabilizing existing foot processes and promoting their effacement and subsequent proteinuria in glomerular diseases Hence, the goals and significance of this study are: 1) To identify the role of FAK activation in the regulation of podocyte injury and repair by utilizing in-vivo and in-vitro methods 2) To use novel FAK inhibitors such as TAE-226 in mouse models of glomerular injury to determine the feasibility of this approach as therapy for patients with proteinuric renal disease. Specific Aim 1- Investigating the Role of FAK in Podocytes Following Injury- In this aim, the importance of FAK activation in LPS-induced podocyte injury will be determined in-vitro using the FAK null and knock- down cell lines that we have established and in-vivo using FAKfl/fl; Pod-Cre and wild type mice. In a second model of podocyte injury, glomerulonephritis will be induced by injection of rabbit-anti-mouse glomerular basement membrane (GBM) antibodies. We will assess the severity of injury and the degree of recovery in both FAKfl/fl; Pod-Cre and wild type mice and determine if the absence of FAK decreases foot process effacement. Hence, these models of podocyte injury will allow us to determine the role of FAK activation in both nephritis (anti-GBM antibody injection) and nephrosis (LPS injection). Specific Aim 2- Determining the Role of FAK Inhibition in Models of Glomerular Injury- Since our preliminary results demonstrate that FAK deletion in podocytes can reduce LPS induced podocyte damage, the FAK inhibitor, TAE-226, will be utilized to determine whether pre-injury or post-injury treatment with this compound can ameliorate proteinuria, hematuria, and renal failure in the two glomerular injury models described in SA1, and the effects of this compound on foot process effacement and podocyte migration. In addition, we will assess the ability of TAE-226 to diminish podocyte foot process effacement and proteinuria and preserve podocyte numbers in the streptozotocin-induced diabetic nephropathy model of chronic kidney disease. Specific Aim 3- Determining the mechanism of FAK-induced podocyte effacement - We have found that podocytes lacking FAK exhibit increased expression of Tissue Inhibitor of Metalloproteinase-2 (TIMP-2), decreased metalloproteinase-2 (MMP-2) activity, and actin rearrangement. The metalloproteinases are enzymes that regulate basement membrane turnover and thus may normally be key effectors of FAK- dependent podocyte-basement membrane interactions. The role of FAK-dependent inhibition of TIMP-2 and activation of MMP-2 in foot process retraction and podocyte migration will therefore be investigated in-vitro as well as in-vivo using the cell lines and knock-out mice described above.